STUDY OF OCULAR GLIAL CELLS INVOLVEMENT IN UVEITIS

Muller cells from adult rat retina are purified and maintained in culture. Culture medium is defined. Interactions with inflammatory mononuclear cells are studied.